Social Determinants of HIV

Social determinants of health (SDH) comprise overlapping social structures and economic systems that
account for most health inequities. Examining SDH may be useful in identifying and monitoring HIV-related
inequities, such as racial and gender disparities in HIV testing, engagement in care, and treatment. This
proposal requests funding for a pre-doctoral research training program to address SDH including structural
racism and gender inequality, intersectional stigma, residential segregation, aging, and marginalizing
structures influencing HIV. Combatting the ongoing syndemic of SDH, HIV, affiliated co-morbidities, and other
potentially overlapping infectious diseases such as Coronavirus, requires cutting edge public health research
conducted by scientists of the highest caliber. This pre-doctoral program will be located in the department of
Sociomedical Sciences within Columbia University, Mailman School of Public Health (MSPH). The training
program will take advantage of the interdisciplinary expertise across MSPH in mentoring experience and
expertise in SDH among people at risk and living with HIV. We also propose to collaborate with faculty at the
HIV Center on Clinical and Behavioral Studies at Columbia University Irving Medical Center (CUIMC), the
International Center for AIDS Care and Treatment Program, at MSPH, and the Social Interventions Group at
the Columbia University School of Social Work. This wealth of faculty have outstanding records in publishing,
funding, and successfully mentoring trainees. We propose to fund ten MSPH pre-doctoral fellows.
Recruitment will be focused such that at least 50% of fellows enrolled will be under-represented trainees.
Eligible trainees are pre-doctoral students admitted to Columbia University's MSPH departments of
Sociomedical Sciences, Biostatistics, Epidemiology, and Population and Family Health, and committed to
understanding social determinants of HIV. Trainees are required to complete in their primary department,
specific theoretical, methodological, and biostatistical pre-doctoral department requirements. All fellows will
receive mentoring and co-mentoring and will be required to complete the following training components: (1) a
Faculty-Fellow seminar that alternates hosting guest speakers discussing professional development, structural
interventions, social policies, community-engaged research, and social determinants of HIV, with a student-led
journal club, (2) coursework on social and economic determinants of health, (3) coursework on social
epidemiology, (4) coursework on HIV, (5) coursework on multilevel modeling, (6) attendance in HIV Grand
Rounds at CUIMC, (7) a course in the responsible conduct of research, (8) grantsmanship, (9) experiential
training to hone publication, and presentation skills, and (10) doctoral research on the social determinants of
HIV. This pre-doctoral program aims to prepare MSPH students for research and teaching careers that
examine SHD, and marginalizing structural factors that influence HIV, nationally and globally.

Public health relevance
Columbia University Mailman School of Public Health requests funding for a pre-doctoral research training program to address SDH including structural racism and gender inequality, intersectional stigma, residential segregation, aging, and marginalizing structures influencing HIV. All pre-doctoral students receive training in social determinants of health, HIV, and grantsmanship. This pre-doctoral program aims to prepare MSPH students for research and teaching careers that examine SHD, and marginalizing structural factors that influence HIV, nationally and globally.